Interactive Transition Support for Adolescents Living with HIV Comparing Virtual and In-person delivery through a stepped-wedge cluster randomized clinical trial in South Africa

Project Summary: Significance: South Africa has the highest number of adolescents living with HIV in the
world with KwaZulu-Natal the epicenter, yet adolescents are poorly prepared for transition from pediatric to adult
services as evidenced by poor retention in care and viral suppression after transition. In-person and mHealth
adolescent-friendly interventions have potential to remedy the disparities for adolescents living with HIV in low
to middle income countries but larger, powered randomized trials are needed. Differentiated care: Transition
readiness assessments can be used to identify the more vulnerable adolescents and focus resources on
adolescents who would benefit most from additional interventions. Innovation: This study is the first study to
evaluate interventions to support transition from pediatric to adult care for adolescents living with HIV in sub-
Saharan Africa. mHealth has not previously been used to address the critical transition period for adolescents
living with HIV. We hypothesize that in-person or mHealth adolescent-friendly interventions will improve viral
suppression for adolescents living with HIV with low to intermediate transition readiness as they transition to
adult care. We also hypothesize that mHealth interventions can provide equal benefits to in-person interventions
with lower costs, broader reach, and easier adoption. Approach: Using a Type I hybrid effectiveness-
implementation design, we will evaluate the effectiveness of in-person or mHealth delivered adolescent-friendly
transition interventions for adolescents living with HIV with low to intermediate transition readiness. Using a
stepped-wedge, delayed implementation randomized clinical trial design we will measure the effectiveness of
the interventions compared to standard of care on viral suppression and retention in care (Aim 1).
Simultaneously, we will use the RE-AIM framework to measure the implementation factors associated with the
implementation strategies of peer educators as clinic champions and audit and feedback (Aim 2). We will also
determine if the interventions lead to changes in transition readiness scores and their underlying domains for
future targeted interventions further differentiating care based on transition readiness (Aim 3). Investigators:
Multiple Principal Investigators: Brian Zanoni has been working in adolescent HIV in South Africa since 2006,
has received NIH funding through an R21 to develop the transition readiness assessment and K23 to develop
and pilot the mHealth intervention used in this proposal. Monerndran Archary is an expert in pediatric and
adolescent HIV in South Africa. He and Dr. Zanoni have been working together since 2011 in developing
transition readiness assessments and interventions to improve adolescent transition care. Co-investigators:
Maryam Shahmanesh is an expert in clinical trials among youth in rural KwaZulu-Natal, South Africa. Jessica
Haberer is an expert in the development and implementation of mHealth interventions for people living with HIV.
Vincent Marconi is an expert in implementation science and translational research in South Africa. Kathy Baisley
is a senior statistician with expertise in clinical trials including stepped-wedge designs.

Public health relevance
Project Narrative: With antiretroviral therapy, children living with perinatally-acquired HIV are surviving into adulthood and will need to transition to adult care to achieve long-term successful outcomes. Adolescents living with HIV and transitioning to adult care have shown high rates of mortality, virologic failure, and loss to follow up. The proposed research will evaluate in-person and mHealth delivered adolescent-friendly transition interventions compared to standard of care among adolescents with low transition readiness in a randomized clinical trial and evaluate implementation factors associated with each intervention in urban and rural settings.